The Alara Imaging Gateway: Linking Electronic Health Records and Radiology Imaging Exams to Report on National Quality Measures to Reduce Cancer Risk from Computed Tomography (Alara Imaging Gateway)

Abstract
Alara Imaging, Inc. (Alara) is seeking funding to support the development of robust, IP-protected, HIPAA-
compliant commercial quality software to calculate and report on quality measures that will be reported for
every radiologist and hospital group in the nation. Further, Alara is seeking funding to develop enhanced
feedback that leverages machine learning, data visualization, and benchmarking to guide physicians and
hospitals on safe approaches for lowering their CT radiation doses. Once implemented at scale through the
support of this award, Alara’s software has the potential to reduce the cancers that result from CT by up to
30%, preventing as many as 10,000 cancers annually.
The use of CT has grown substantially over the last 2 decades with 90 million CT exams performed annually in
the U.S. A major quality gap exists in the performance of CT as the radiation doses used for these exams are
higher than needed for diagnosis and in the range where they increase a person's risk of developing cancer; it
is estimated that CT use causes 36,000 cancers annually in the U.S.1 The inconsistency in how CT exams are
performed represents a modifiable health risk as radiation doses can be reduced through audit and feedback,
as shown in a UCSF led, NCI funded, trial.2
In 2019, UCSF was awarded a cooperative agreement from CMS to develop CT radiation dose and image
quality measures for use in the agency’s pay-for-performance programs. The intent of this award was to
motivate radiologists and hospitals and to reduce unnecessarily high radiation doses through financial
incentives. UCSF created the approach to judge each CT by combining clinical and radiology data located in
disparate health data systems including the Electronic Health Record, Radiology Information System, and
Picture Archiving and Communication System. These data systems communicate poorly, and properly
ingesting and normalizing these data in real time was a technological challenge. Additionally, as a stipulation of
the funding, CMS required UCSF to develop these measures as electronic clinical quality measures (eCQM);
however, the resources required to develop and implement an eCQM at the national level were beyond what
was available to Dr. Smith-Bindman from CMS. As a result, Dr. Smith-Bindman, in collaboration with UCSF as
a minority equity stakeholder, worked with radiology informatics experts to create a commercial entity, Alara, to
develop the eCQMs and software for national implementation. The measures are now being considered for
use in CMS quality payment programs, and Alara is now seeking funding to implement the measures at scale.
In addition to the CMS measure functionality, the software’s architecture will represent a meaningful
technological advancement and creates value beyond measure reporting by linking and providing access to
combined clinical and radiology data connected to the cloud. Information technology companies that are
driving care forward in radiology using novel machine learning and computer vision techniques need access to
the same linked data so that they can leverage modern technology applications. Alara’s software, “The
Gateway”, solves this integration and data access challenge, and Alara will sell access to the Gateway to
technology companies, opening possibilities for technology companies to develop additional solutions that take
advantage of the linked and structured data.

Public health relevance
Project Narrative A quality gap exists in the performance of computed tomography (CT) as radiation doses are higher than needed for diagnosis and vary depending on where a patient goes for care. Alara Imaging has developed patient safety measures that are focused on the radiation dose and image quality for CT and are being considered for use in the Centers for Medicare and Medicaid Services (CMS) quality payment programs; the use of these measures has the potential to reduce the doses used for CT to make CT safer. Alara Imaging is seeking funding to support the development of commercially built software that hospitals and physicians can use to report on these measures as well as seeking funding to build software to help guide physicians to lower the doses they use for CT.